National Health & Nutrition Examination Survey 2011-12 & 1013-14 Physical Activit

To provide support for the Physical Activity/Sleep and Strength Components in NHANES. This component will involve providing an accelerometer-based monitor to survey participants ages 6+ years and request that the monitor be worn around the clock on the wrist for seven days. The device will collect movement data to provide information about PA as well as the duration and efficiency of sleep. For the Strength component participants ages 12+ years will be asked to squeeze a hand-grip dynamometer with each hand and the strength of the squeeze will be recorded. The measure of grip strength has been shown to be a good proxy for total body strength.